Ambystoma Genetic Stock Center

RESOURCE COMPONENT - PROJECT SUMMARY
This component provides details about AGSC operations. During the 2025-2030 funding period, the AGSC will
continue to generate and import high quality, axolotl stocks and innovate new husbandry methods, services,
and protocols. The AGSC will offer a formal workshop to provide training in axolotl husbandry and embryo
microinjection at UK, and AGSC staff will develop and present educational activities in local K-12 schools.
A financial plan is described that will ensure long-term sustainability of axolotl stocks and move the AGSC
each year towards greater self-sufficiency. Also, plans are presented to share methods, protocols, and data.
The AGSC is a proven axolotl resource provider and will continue to ensure distribution and long-term
sustainability of axolotl stocks to NIH investigators.